Attention allocation as a computational mechanism for altered sensory processing in autism

PROJECT SUMMARY/ABSTRACT
Autism spectrum disorder (ASD) is a complex disorder of brain development characterized by difficulties in
social interaction and communication and the presence of restricted and repetitive behaviors and is often
accompanied by disruptions of sensory and perceptual processing. Altered sensory and perceptual processing
leads to a range of individual experiences including heightened and dampened sensory reactions that can
profoundly affect quality of life. Despite the prominence of sensory and perceptual symptoms in ASD there is
no unifying explanation for their etiology. The central premise of this proposal is that the sensory and
perceptual processing differences that occur in ASD derive from differences in attention. Specifically, we will
test the hypothesis that spatial- and feature-based attention is more narrowly focused and that rapid
oscillations of attention occur at a slower rate in people with ASD. Our proposal employs computational models
of visual cortical responses in combination with psychophysical and brain imaging measures of neural
responses. Overall, our results will significantly advance understanding of the neural and computational basis
of sensory and perceptual changes in ASD.

Public health relevance
PROJECT NARRATIVE This research will test the hypothesis that a change in how attention is allocated forms the basis of sensory and perceptual processing differences in autism spectrum disorder (ASD). Using brain imaging and behavioral measures, the research will advance our basic understanding of the neural basis for sensory and perceptual processing differences that are commonly observed in ASD.